Tumor stem cell initiated mitochondrial transfer

Project Summary/Abstract
Cancer is a metabolically heterogeneous disease. At the core of most metabolic pathways, mitochondria play
central roles in cancer cell proliferation, migration, invasion, metastasis and therapeutic resistance. Due to
significant amount of somatic and germline mutations, cancer-relevant modifications in mitochondria are found.
While some mitochondrial modifications provide aggressive advantages to cancer cells, others are detrimental.
More understandings of how cancer cells manipulate mitochondrial modifications, replenish mitochondrial
repertoire, and regulate mitochondria related metabolisms would therefore hold great promises to tackle
cancer down. Supported by our preliminary work, we hypothesize that a small population of cancer cells, the
cancer stem cells (also known as cancer initiating cells), can horizontally transfer their mitochondria to
macrophages. Due to the predisposed modifications in mitochondria of cancer stem cells, we further
hypothesize that these cancer stem cells derived mitochondria could rewire metabolic pathways in
macrophages thus leading to alternative activation of macrophages (M2). The hypotheses will be tested by two
specific aims. We will initially test the reproducibility of the horizontal transfer of mitochondria initiated by
different types of cancers (Aim 1). We will also determine if such mitochondrial transfer is actively conducted
by cancer stem cells or passively achieved via phagocytosis by macrophages (Aim1). Once the mitochondria
of cancer stem cells are present in macrophages, we will examine how these mitochondria mask arginine
metabolism, oxidative phosphorylation and reactive oxygen species production in macrophages (Aim2).
Additionally, we will determine the polarization spectrum of macrophages in response to the acquisition of
exogenous mitochondria from cancer stem cells (Aim 2). With successful completion of this proposal, the
information collected from this R03 will not only provide new insights of new immune evasion mediated through
the horizontally mitochondrial transfer from cancer stem cells but also present an enticing target for more
effective therapeutic interventions specifically targeting the cancer stem cells or the tumor associated
macrophages. In addition, it may also serve as a proof-of-principle to apply to other types of stromal cells that
may account for other cancer related diseases.

Public health relevance
Project Narrative Tumor stem cells are the major players involved in tumor metastasis, immune evasion, therapeutic resistance, and relapse and therefore are closely related to cancer deaths. In the proposed R03 application, we aim to study a new mechanism on how tumor stem cells mask immune macrophage activation and metabolism via actively transferring their malfunctional mitochondria into macrophages. Successful completion of the project will determine a way forward in the development of new therapeutic strategies against tumor stem cells and tumor macrophages and is of paramount importance for cancer community.